Training in Cell and Molecular Biology

Abstract
The University of Virginia is consistently ranked within the top 3 public universities and has a traditional
strength in the areas of cell and molecular biology, where it had discoveries as central as the
mechanism of G-protein signaling, development of the histone code concept and the identification of
Map Kinase. For 35 years the interdisciplinary Cell and Molecular Biology Graduate Program (CMB),
whose 86 faculty from 12 departments and three schools, has been bringing together the best
biomedical graduate students and faculty from across the grounds to generate a training forum that
complements classroom and laboratory experience. Students join an inclusive program in their second
year and remain associated with the program until they graduate. The training focuses on the second
and third years of Ph.D. training employing tools that guide students through the transition from class
knowledge to independent thinking and practical use of the scientific method. The CMB program
intensifies this transformative period by nurturing the students through a series of poster sessions, data
clubs, retreats, writing classes, mixers, and symposia to expose the students to outstanding multi-
disciplinary science from around the university. The program also builds professional skills through
mentor training, workshops on both scientific rigor and reproducibility and ethics, volunteer
opportunities in the Charlottesville community, and consistent exposure to emerging topics that affect
the biomedical community. Our goal is well rounded PhD trainees that can both employ the scientific
method to complex problems and also master the professional skills required for the numerous scientific
career choices of the 21st century. The past success of our trainees in both academic and nonacademic
scientific careers demonstrates that the CMB program prepares students to become leaders of
biomedical sciences.

Public health relevance
In the 21st century the biomedical sciences will have ever increasing roles in improving health as well as acting as an engine of economic growth, so it is central to America's future to train the next generation of biomedical scientists. At the center of the biological revolution has been the understanding of basic cell mechanics using cell and molecular biology techniques. For 35 years the Cell and Molecular Biology graduate training program at the University of Virginia has turned out leaders in biological research that populate laboratories in companies, thinktanks and universities throughout the country. This has always been an inclusive program that has had over 20% of its trainees from under represented populations and produced outstanding graduation rates. This proposal outlines a bold restructuring of this program with the introduction of a number of student- centered activities to modernize our Ph.D. training program and to continue this proud training tradition.